Randomized Double-Blind Placebo-Controlled Trial: fMRI Assessment of Cranial Electrical Stimulation for Fibromyalgia in Veterans

CANDIDATE: Dr. Woodbury is an 8/8 VA-paid employed double-board certified anesthesiologist and pain
management clinician who seeks protected time to develop advanced neuroimaging and clinical trials expertise
following successful completion of a CDA-1 feasibility study. ENVIRONMENT: The Center for Visual and
Neurocognitive Research (CVNR) is a VA RR&D Center of Excellence (COE) in research and provides a
robust clinical research environment in conjunction with nearby Emory University. RESEARCH PLAN: In the
setting of the opioid epidemic, it is crucial to develop non-pharmacologic treatments for pain and biomarkers to
accurately assess pain treatment outcomes. In the present investigation, we assess a novel non-
pharmacologic approach to chronic pain treatment in patients suffering from fibromyalgia (a notoriously difficult
to treat pain syndrome), utilizing neuroimaging as a biomarker. Resting state functional connectivity MRI (rs-
fcMRI), a specific neuroimaging technique, has emerged as a reliable research tool to objectively assess,
understand, and predict clinical pain in syndromes such as fibromyalgia. Preliminary results from our CDA-1
investigation reveal a trend towards improved pain and function with a FDA-approved, non-pharmacologic
therapy - auricular percutaneous electrical neural field stimulation (PENFS) - over standard therapy control,
correlating to altered network connectivity on rs-fcMRI. PENFS-related improvements continued through 12
weeks following the completion of treatment and correlated to changes in cross-network connectivity, which
differed between groups. OBJECTIVE: The proposed CDA-2, a randomized, sham-controlled trial of auricular
PENFS, evaluates 1) the clinical utility of PENFS for fibromyalgia as compared to sham placebo control, 2)
short- and long-term PENFS-related neural changes visualized on rs-fcMRI and 3) the ability of rs-fcMRI to
predict PENFS treatment response. HYPOTHESIS: True PENFS results in non-placebo-related short- and
long-term pain and functional improvements that can be correlated with altered connectivity and predicted by
baseline rs-fcMRI. METHODS: Fifty total subjects (male and female veterans, age 20-60 years old) will be
randomized to either sham (n=25) or true (n=25) auricular PENFS. Neuroimaging data, self-reported pain, and
function will be assessed at baseline and at 1 and 12 weeks post-treatment to evaluate neural correlates of
PENFS-related treatment. Subjects who meet study criteria will receive baseline assessments including rs-
fcMRI, Defense and Veterans Pain Rating Scale (DVPRS) measures, PROMIS measures, arm curl, 30-s chair
stand, handgrip strength tests, and baseline analgesic consumption. Subjects will be block-randomized,
stratified based on gender, to either true or sham PENFS (series of 4, weekly) treatments and assessed for rs-
fcMRI and functional changes at 1 and 12 weeks post-treatment. This study addresses the critical need to
identify and understand neural correlates of pain and non-opioid pain management. CAREER
DEVELOPMENT PLAN: Mentors and collaborators provide direct guidance related to neuroanatomy,
neuroimaging acquisition and analysis, and clinical trials research and data analysis. Didactic coursework and
conference attendance provide clinical trials research (completion of Masters of Science in Clinical Research
curriculum) and advanced neuroimaging skills. Experience and skills gained from the CDA-2 training will be
used to apply for future proposals such as a VA Merit to gain academic independence. IMMEDIATE GOALS:
1) to build upon a foundation of knowledge gained from my CDA-1 in using neuroimaging as a biomarker to
examine the neural correlates of pain and analgesic outcomes, and 2) to leverage the skills learned through
my MSCR and CDA-1 training to conduct a randomized, double-blind, placebo-controlled clinical trial. LONG-
TERM GOAL: to become a successful investigator and international leader in pain research, focusing on 1)
understanding neural correlates of pain, 2) developing more reliable and objective biomarkers for chronic pain
assessment, and 3) assessing non-pharmacologic and opioid-sparing therapies for pain.

Public health relevance
Fibromyalgia is a difficult to treat chronic pain condition that is often treated with opioids despite the lack of evidence supporting opioid use. Veterans returning from the Gulf War are at increased risk of fibromyalgia, and many treatment options for fibromyalgia are either inadequate or have harmful side effects. PENFS (percutaneous electrical neural field stimulation) is an FDA-approved therapy similar to acupuncture applied to the external ear. It is currently utilized within the military and VA system, but needs to be further investigated. One way to investigate pain and pain relief is to use a special kind of MRI called resting state functional connectivity MRI (rs-fcMRI) to evaluate changes in brain activity at rest. Using rs-fcMRI to understand whether PENFS works and how it works could lead to improvements in pain management and quality of life, reduced dependence on opioids, and development of new techniques to address and assess pain.